Linking Hippocampal Replay Content to Learning and Decision-Making

PROJECT SUMMARY / ABSTRACT
Memory is an integral component of human cognition, and when memory processes go awry, the result is
devastating neurological disorders of memory loss including Alzheimer's disease and other forms of dementia.
One essential role of normal memory processes is to use previous experience to guide decisions about future
actions. Thus, research to define the neural mechanisms of memory processes is important to understand both
normal brain function and what goes wrong in memory loss disorders. Further, insights from these studies could
help develop new treatments for these disorders. Recent work showed that synchronized neuron firing events in
the hippocampus called sharp wave ripples (SWRs) that occur during awake immobility are required for rapid
learning during spatial memory tasks. SWRs often contain specific place-cell firing sequences that closely
resemble firing during prior experiences (“replay” events), suggesting a potential neural mechanism for retrieval
of specific prior experiences. However, not all awake SWRs contain replay events that encode experiences
related to the current environment, and so whether the specific content of replay is required for learning remains
an unanswered question. I hypothesize that content-specific replay events serve to retrieve specific prior
experiences and so are required for learning and decision-making. To date, this hypothesis has not been directly
tested and the lack of tests is a major gap in our understanding of neural mechanisms of memory processes. In
preliminary work, I have developed a system that decodes and classifies replay events in real-time and can
provide behavioral or neural feedback based on the content of a replay event. I will use this system to test three
related hypotheses, (1) replay content can be modulated by behavioral conditioning, (2) specific replay content
can drive behavior, and (3) specific replay content is required for learning. In addition to these experiments, my
fellowship training plan includes research and academic goals. My research goals are to investigate fundamental
neural mechanisms of memory processes and to learn the methods of in vivo physiology and computational
neuroscience. My academic goals are to build a strong foundation in computational neuroscience and continue
to improve the career development skills I will need for my transition to independence at the end of this fellowship.
Together, the labs of my sponsor, Loren Frank, and co-sponsor, Uri Eden, and the UCSF scientific community
will provide an excellent training environment. Dr. Frank is a leading expert in the field of chronic hippocampal
recording and neural data analysis methods. Dr. Eden is an expert in methods of computational and theoretical
neuroscience, including the algorithms I will use in my experiments. UCSF is a premier academic research
institution for medicine and neurobiology with a strong focus on collaboration and plentiful career development
resources for postdoctoral fellows.

Public health relevance
PROJECT NARRATIVE The research proposed in this application will employ cutting edge, real-time algorithms to test hypotheses about the neural mechanisms of fundamental memory processes. The results will provide insights into how specific activity patterns in the brain drive memory and learning and have the potential to assist in the development of interventional therapies for human memory disorders.